Adapting and testing a physical activity dyad intervention for Black girls with asthma and their mothers

PROJECT SUMMARY/ABSTRACT
Physical inactivity is associated with poor asthma control and lower quality of life. Rates of physical inactivity,
asthma, and asthma mortality among Black girls are higher than their White counterparts. Our formative work
identified barriers to physical activity among Black women with asthma and led to the development of a
culturally tailored physical activity intervention for Black women with asthma (ACTION: A lifestyle physical
activity intervention for minority women with asthma). The goal of this study is to adapt the intervention for
Black girls with asthma using a dyad approach. We will engage urban Black girls (8-12 years) with asthma and
their mothers in interviews to understand how the ACTION intervention should be modified to fit the needs of
urban Black girls with asthma. We will modify and then pilot test the intervention (Mothers and Daughters in
ACTION). This study will provide the first ever evidence of a family-based lifestyle physical activity intervention
culturally tailored for urban Black girls with asthma, a population that is understudied yet plagued by low levels
of physical activity and poor health outcomes. We have assembled a multidisciplinary team that has the
necessary expertise to carry out the proposed study, including in asthma, physical activity, dyad interventions,
program development, qualitative methods, as well as observational and randomized studies. This award will
provide the infrastructure and data about feasibility and preliminary efficacy to apply for funding (NIMHD R01
RFA-MD-22-007) to rigorously test the efficacy of the Mothers and Daughters in ACTION and advance
management of asthma in minority populations living in low-resourced urban environments.

Public health relevance
PROJECT NARRATIVE Physical inactivity is associated with worse asthma outcomes, and Black girls are disproportionately impacted by both physical inactivity and asthma morbidity. Family-based approaches to increasing physical activity are more effective and sustainable, yet no study to date addresses the unique asthma-related, culture-specific, and multi-level barriers to physical activity. This project aims to apply a theory-based approach to develop the first evidence for a dyad lifestyle physical activity intervention that is culturally tailored for urban Black girls with asthma, with the goal of improving outcomes and reducing disparities for Black girls with asthma.